DIDEOXYCYTIDINE (DDC) DRUG INTERACTION STUDY WITH DAPSONE AND ISONIAZID IN HIV

The purpose of this study is to examine whether dideoxycytidine will interact with dapsone and isoniazid when given in combination to patients infected with HIV.